Multidimensional Optimization of Voltage Indicators for In Vivo Neural Activity Imaging

In recent years there has been much excitement about genetically encoded fluorescent indicators of neural
activity, with new molecules such as the genetically encoded calcium indicator GCaMP6 being used to image
the activity of many neurons at once in living brains. However, such indicators are slow, raising the question of
whether voltage indicators will become useful enough to be widespread in neuroscience. Furthermore, imaging
of axons and dendrites remains difficult, especially in densely expressing tissues. For example, when neurons
express such reporters densely, axons and dendrites within the diffraction limit of light will have their signals
mixed, so that the signals of individual neural processes cannot be resolved. How can we push the
spatiotemporal performance of neural activity imaging to the specifications desired by neuroscientists – down to
the millisecond timescale, and down to the sub-micron scale axonal and dendritic parts of neurons? We here
propose to address this problem through molecular engineering, guided by in vivo imaging constraints. To
address the spatial dimension: if neural activity indicators could be safely clustered into discrete, bright puncta
that, even when expressed in all the cells of a neural circuit, are separated from one another by a distance
greater than the diffraction limit of the imaging system, then these puncta could cleanly be imaged, and used to
sample activity along axons and dendrites of the neurons in a circuit. In this grant, we will (Aim 1) create and
validate this strategy, which we call stochastic arrangement of reagents in clusters (STARC). In this way, we
will effectively point the way towards circuit-wide neural activity imaging that allows for the investigation of axonal
signaling and dendritic processing, and not only cell body imaging. To address the temporal dimension: we will
create optimized fluorescent voltage indicators (Aim 2). Pioneering efforts have resulted in fluorescent voltage
indicators, but their performance is often poor when utilized in the brain, because of poor trafficking and
membrane localization that manifests in vivo, since neurons in vivo are different from the cultured cells used to
screen for the voltage sensors. We will conduct an in situ screen to directly identify fluorescent voltage indicators
that work well in neurons in intact mouse brain circuits, by virally expressing members of a library of mutant
voltage indicators directly in the mouse brain, imaging the responses with single cell resolution in mouse brain
slices, and then directly reading out the mutations that yielded the voltage indicators that best perform in actual
brain circuits, validating the resultant indicators in the mouse brain. We will also create (Aim 3) STARC forms
of voltage sensors, since the proximity issues discussed in Aim 1 are even more severe when a neural activity
reporter is on a neural membrane that is in close proximity to other membranes. We will close the loop by testing
all such indicators in vivo and then iterating on the molecular engineering, delivering to the neuroscience
community a powerful, simple-to-use toolbox that can be rapidly deployed for ultraprecise – across both space
(via STARC) and time (via in situ optimized voltage indicators) -- neural activity imaging.

Public health relevance
The proposed research is relevant to public health because it will bring forth into neuroscience a powerful toolset that enables the mapping of neural activity throughout brain circuits, with spatial and temporal performance equal to the neural codes of the brain. This technology will thus enable the pinpointing of disease mechanisms, as well as new clinical targets, in a systematic and precise fashion.